Development of COVID-19 and Cancer Tools with Artificial Intelligence

Public data posting of CT scans on public NCI TCIA websites were made. AI deep learning models were made alongside of multiple industry partners, to educate on the serial temporal dynamics of COVID-19. AI deep learning models were built and publicly posted for research purposes that automatically segment COVID-19 opacities and classify COVID-19 on an initial point of care CT scan, built on multi-national training data. NIH CC and NCI were among the first to gather multi-national data and develop freeware public AI solutions based on COVID CTs for both academic and commercial developer use. A uniform and validated imaging biomarker solution for use for a clinical trial setting could expedite the pathway towards drug discovery and early validation or response signals. Federated learning was piloted with academic and industry partners in several projects in Nature Medicine and JAMIA publications. The NIH team is working with commercial and academic partners to assess deep learning tools in cancer. Ongoing work will attempt to deploy voice models deployed on smartphopnes for pre-screening settings. It was shown that pre-symptomatic CT AI can track disease in a predictable fashion, and that this disease dynamic curve is recapitulated in a non-human primate model of COVID-19. Prior work with extramural partners has demonstrated that federated learning can overcome shortcomings in unbalanced source data for imaging AI, and that the application of a specific federated learning technique can overcome the gap, thus showing that the data does not need to be shared in order to build quality AI models from medical imaging. This effort cross links with numerous campus efforts, including preclinical NIAID efforts, NCI/CCR efforts within AI Resource, and extramural partners in Bridge to AI. CC/NCI team members also deployed a 3D-printed miniature ventilator in swine (now commercialized) as well as a disposable isolation bag device with in-line air filtration. CT AI models were licensed to industry. Highly impactful AI models were developed and licensed towards the detection, characterization, and assessment of prostate cancer using MRI and MRI-US fusion biopsy. These models may have broad scope impact.